Regulation of transendothelial migration of Tregs in irradiated HNSCCs by EphB4-ephrinB2 interaction

Abstract
Resistance to radiation therapy (RT) remains a challenging problem for high-risk head and neck squamous cell
carcinoma (HNSCC) patients. Anti-PD1 is now approved in the first- and second-line settings, indicating that the
majority of these tumors are resistant to treatment. The field awaits the results of multiple trials testing whether
combining immunotherapy and RT can help avoid resistance to RT, but many preclinical studies (including those
from our lab) indicate that treatment resistance still develops despite such combinations. The preferential
recruitment of unique immunosuppressive cell subtypes after RT to the tumor microenvironment (TME) in
response to RT plays an important role in contributing to the promotion of tumor growth and progression. The
tumor endothelium can act as a selective barrier that regulates the entry, stability, and activation status of
immune cells, but the mechanistic underpinnings of this barrier activity remain poorly understood. The EphB4
receptor tyrosine kinase and its ligand ephrinB2 define novel molecular targets. Upon cell to cell contact, both
EphB4 and ephrinB2 can signal via their cytoplasmic domains. Though they have been extensively studied in
cell migration and angiogenesis in early embryonic development, little has been published on their role in
modulating the cancer immune microenvironment. Our data show that ephrinB2 is expressed on the tumor
vasculature and is upregulated by RT and that EphB4 is expressed on immunosuppressive regulatory T cells
(Tregs). Inhibiting EphB4-ephrinB2 interaction with a peptide (TNYL-RAW) results in the selective, and exclusive,
reduction in infiltration of Tregs while increasing activation of CD8+ and CD4+Foxp3- T cell populations. Tregs,
we have demonstrated, play a key role in the development of resistance to RT, and their depletion re-establishes
responsiveness to therapy in HNSCC murine models. We hypothesize that RT’s upregulation of ephrinB2 on
tumor endothelial cells acts preferentially on EphB4 expressing Tregs, and blocking this interaction reduces their
intratumoral infiltration and survival, which allows CD8+ and CD4+ effector cells to induce tumor regression. In
Aim 1, we will analyze the mechanistic outcomes of Treg EphB4 and endothelial ephrinB2 interaction on Treg
transendothelial trafficking, intratumoral homing, and survival using genetically engineered animal models with
ephrinB2 deleted on endothelial cells or EphB4 deletion on Tregs after RT. In Aim 2, we will interrogate the
cellular and molecular mechanisms triggered by the interaction between endothelial ephrinB2 and EphB4-
expressing Tregs in endothelial-Treg co-culture assays after RT. Targeted inhibition of STAT3, AKT, Erk
pathways will be done with pharmacological inhibitors based on our preliminary data. We expect that these
studies will elucidate the molecular and cellular parameters of EphB4-ephrinB2 inhibitors and will provide the
necessary information to develop a more effective therapy for RT resistant HNSCC.

Public health relevance
Narrative In head and neck cancer, immune cells undergo phenotypic and physiological changes in response to radiation therapy that promote tumor growth and progression after radiation therapy. Regulatory T cells (Tregs) are abundant in tumors resistant to radiation therapy and take an active part in generating an immune suppressive microenvironment. We aim to determine how interactions between the EphB4 receptor tyrosine kinase and its ligand ephrinB2 at the tumor endothelium-immune cell interface selectively promote a Treg-rich microenvironment and thereby support tumor growth.